Administrative Core

ADMINISTRATIVE CORE-ABSTRACT
The Administrative Core will assume a multi-faceted role within the NYCenter for Minority Health, Equity, and
Social Justice (NYC-MHESJ), orchestrating the key functions that drive the Center's effectiveness. It will: 1)
effectively manage program resources to ensure optimal utilization to maximize the program's impact on the
communities served and 2) evaluate the impact of each core and the Center to enhance institutional research
capacity and promote career development activities.
The Specific Aims of this Core are:
1) To maximize the program's impact, provide Administrative and Logistics Support to the NYC-MHESJ
resources effectively. We will: a) efficiently manage program resources to ensure their optimal utilization
to maximize the program’s impact on the communities it serves; b) provide administrative oversight and
ensure consistent communication among all cores and NIMHD; and c) efficiently coordinate the activities of
the Internal Advisory Board and External Scientific Advisory Board ensuring that their recommendations are
implemented across the program to foster innovation and continuous quality improvement for the program.
2) Implement programmatic/career enhancement activities to support scientists by guiding them
through developing a mentoring grant submission timeline and facilitating their progress. The
Administrative Core, in partnership with the Investigator Development Core, will monitor the investigator’s
progress and, with their mentoring committees, will facilitate the procurement of funding at the R01 level.
3) Develop and implement a plan to self-evaluate short-term and long-term goals, including
implementing and tracking program activities, ensuring alignment with the Center's overarching mission
and objectives.
Internal strategic communications will be transformative by unifying the cores, projects, and disciplines into a
seamless transdisciplinary endeavor. It involves identifying, articulating, guiding, and realizing the Center's
strategic messages, fostering a shared understanding and purpose among all stakeholders. External strategic
communications, led by the Community Engagement Core, will effectively disseminate the Center's findings to
our crucial stakeholders: the communities we aim to learn from and serve. With strong leadership, informed by
our evaluative approaches, this Core will significantly contribute to the success of our program. It will pave the
way for substantial advancements in health disparities research to reduce health disparities and positively
impact the health of communities we are dedicated to supporting and serving. Through these multi-faceted
responsibilities, the Administrative Core is pivotal in shaping the Center's impactful contributions to health
disparities research.

Public health relevance
Per Funding Opportunity Announcement (FOA) Number RFA-MD-24-001 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.